Development of delivery methods for combination microRNA treatment of alcohol-associated liver disease

PROJECT SUMMARY
Alcohol-associated liver disease (AALD) is a major and growing health concern with limited treatment options.
The natural history of AALD (formerly known as alcoholic liver disease) includes fatty liver disease, alcoholic
hepatitis and the development of fibrosis preceding end-stage cirrhosis. MicroRNAs (miRNAs) represent a new
class of therapeutics due to their ability to simultaneously affect multiple fibrosis-associated pathways. Among
possible targets, miR-155 is involved in inflammatory responses mediated by Kupffer cells (KCs) that affect
fibrogenic events in multiple other hepatic cells. Chemokine receptor CXCR4 and its cognate ligand stromal cell-
derived factor-1 play important and complex roles in the pathogenesis of AALD, including the coordination of the
initial immune reaction upon liver injury and later in controlling the progression of liver fibrosis through its
activating effect on hepatic stellate cells (HSCs) and collagen production. The goal of this project is to develop
integrated miRNA delivery platform based on self-assembled nanoparticles (polyplexes) that deliver anti-miR-
155 to activated KCs and in parallel inhibit CXCR4 signaling in activated HSCs in the liver. The delivery platform
is based on innovative CXCR4 inhibitors based on cyclam-modified low molecular weight poly(ethylenimine)s
(C-PEI) that efficiently encapsulate and systemically deliver miRNA. The objective is to test the hypothesis that
C-PEI/miRNA will lead to enhanced combination effect due to attenuation of profibrogenic signaling of both
hepatic macrophages and the matrix-producing HSCs. We will accomplish the overall objectives in three specific
aims. In Aim 1, we will optimize formulation of the C-PEI-miRNA nanoparticles that deliver anti-miR-155 in liver
fibrosis. Based on encouraging antifibrotic activity in our preliminary studies, we hypothesize that polyplex
modification with mannose and with stabilizing cholesterol moieties will result in efficient delivery of the miRNA
to activated KCs, while excess free C-PEI will target activated HSCs. In Aim 2, we will test the in vivo therapeutic
efficacy of the polyplexes in the bile-duct ligation (BDL) model and mouse models of chronic alcohol
administration with exposure to CCl4. The goal is to conduct comprehensive evaluation of therapeutic efficacy of
the optimized C-PEI-Chol/anti-miR-155 polyplexes in different models and multiple stages of fibrosis. The
findings from the mouse models will be validated in cultured human precision-cut liver slices. In Aim 3, we will
determine the mechanism of antifibrotic activity of the combined miR-155 and CXCR4 inhibition. Although our
preliminary data are consistent with miR-155 downregulation in KCs and inhibition of CXCR4 in activated HSCs,
the precise mechanism of action of the C-PEI/anti-miR-155 polyplexes is not known. Therefore, the studies in
this aim will be designed to ascertain the underlying mechanisms of action of the polyplexes. Overall, this project
will contribute to the fundamental understanding of the role and therapeutic potential of CXCR4 and miR-155
inhibition in AALD and will innovatively address targeted delivery of drug/miRNA combinations as an anti-fibrotic
treatment.

Public health relevance
PROJECT NARRATIVE Alcohol-associated liver disease (AALD) is a major and growing health concern with limited treatment options. There is a critical need to develop novel therapeutic approaches to treat AALD, especially at the pivotal and reversible stages of liver fibrosis. The proposed research is relevant to public health because it will address the need for better treatment options by formulating and testing new combination delivery methods of therapeutic microRNA designed to inhibit two critical targets in the development of alcohol-associated liver fibrosis. Our approach will also contribute to fundamental understanding of hepatic delivery of self-assembled nanoparticles and innovatively address problems in the delivery of drug/miRNA combinations to improve therapy of liver fibrosis.